Novel lead compound advancement for mitigating halogen-induced mortality and morbidity.

Summary: Chlorine and bromine (Cl2 and Br2) are highly reactive and extremely toxic halogen gases that cause
debilitating cardiopulmonary injury and death. Research from our previously funded ‘Identification of Therapeutic
Lead Compounds U01’ provided published and preliminary data that identified calpain inhibitor (CI) as highly
efficacious and safe antidote for Br2 inhalation-induced cardiopulmonary injury and mortality. These studies were
carried out in our unique halogen exposure facility and the discovery of the mitigating agent was made possible
by the development of the Cl2/Br2 exposure-induced rat model of acute cardiopulmonary damage and mortality.
Using the whole body Br2 exposure rat model we demonstrated that the therapeutic action of CIs is caused by
reduction in Br2 induced calpain activity, reduction of proteolysis of the myocardium and preservation of cardiac
function leading to decreased mortality. Calpains (calcium dependent proteases) are activated by Br2/Br2
reactant-induced loss of cardiac sarcoendoplasmic reticulum Ca2+ ATPase, SERCA activity and subsequent
catastrophic cytosolic Ca2+ overload. Intraperitoneal administration of a CI (that was selected from several
commercially available CIs based on an ex-vivo high-throuput evaluation of cardiac calpain inhibition) 1h after
Br2 exposure significantly mitigated acute increase in cardiac calpain activity, decreased Br2-induced mortality.
Administration of CI significantly improved the clinical scores, heart rate and oxygen saturation. Br2-induced
pulmonary edema and cardiac hypertrophy was also reduced. Several cardiovascular parameters such as blood
pressure, ventricular pressure, cardiac output and other diastolic and systolic heart functions were improved in
Br2-exposed animals after CI treatment. We have also initiated the studies on its various structural analogs.
These structures were characterized for their improved solubility, bioavailability and stability. Preliminary data
for their activity and cellular toxicity was also evaluated. Thus, as mentioned in the CounterACT FOA we provided
validation of molecular targets for therapeutic development, proof of in vitro activity of the lead compound,
preliminary in vivo proof-of-concept efficacy data, and preliminary adsorption, distribution, metabolism, excretion,
and toxicity (ADME/Tox) evaluations. Therefore, this lead compound ‘calpain inhibitor’ is now ready for
optimization and we will also evaluate ADME/safety profile of the CI and its most effective analog. Optimization
of CI/analog dose and delivery in a large animal model of halogen-induced cardiopulmonary injury will also be
performed. These studies will allow the lead compound to move forward and help design the pivotal studies
needed for regulatory FDA approval of CI under the animal rule.

Public health relevance
Project Narrative: Chlorine and bromine (Cl2 and Br2) are highly reactive and extremely toxic halogen gases that cause debilitating cardiopulmonary injury and death and effective therapies against such injuries are urgently needed. Our studies have provided confirmation of molecular targets for therapeutic development, proof of in vitro activity and in vivo proof-of-concept efficacy data for calpain inhibition based lead compound. These studies will allow calpain inhibitors or its analog to move forward and help design the pivotal safety and efficacy studies needed for regulatory FDA approval under the animal rule.